Wastewater Analysis of SARS CoV-2 in Tribal Communities

ABSTRACT
The rapid onset of the COVID-19 pandemic left many across the world unprepared to test, treat, and plan for
coronavirus morbidity and mortality. This was true for Tribal nations, whose sovereign status enabled swift and
preventative measures such as lock-downs and border closures, yet whose culture contributed to additional
unique risk factors. Among those are testing disparities, underlying health factors, and community infrastructure.
However, clinical testing doesn’t capture the extent of positive cases, and without the collective efforts of this
project, Tribes will likely not be included in wastewater-based epidemiology (WBE) analysis, which has garnered
wide-spread interest due to its ability to generate data in advance of community infectivity. In this project, we will
show that WBE is a non-invasive, culturally appropriate biomonitoring strategy that can be adopted and
implemented by Tribal communities to empower them with a practical, yet technologically advanced health
surveillance tool. Building upon a rigorous methodology of Tribal consultation and community-based participatory
research, assessment of wastewater and community infrastructure, and training of Tribal wastewater operators
and health administrators on WBE, we will form the WBE Tribal Coordination Center. Tribes will be recruited
through the InterTribal Council of Arizona’s National Tribal Water and Wastewater Operator Training Program
network. We will measure coronavirus in wastewater across U.S. reservations using established RT-qPCR
techniques and a novel protein quantification method, and we will sequence viral RNA extracts to assess SARS-
CoV-2 variants in Tribal communities. Risk factors contributing to elevated COVID-19 in Tribal communities will
be quantified with integration of geospatial analysis. Frameworks for risks from numerous environmentally-
transmitted pathogens have been developed by our team, setting a foundation to incorporate variability and
uncertainty for Tribal settings with qualitative information from Tribes in order to appropriately scope our modeling
efforts. Simulation results will help to target resources efficiently for monitoring and public health interventions
by identifying specific sampling locations where it is most likely to detect SARS-CoV-2 given other community
and scientific constraints. Information from the RADx Data Coordination Center will be used to the fullest extent
to compare Tribal communities with their non-Tribal counterparts. Through the coronavirus pandemic and
beyond, Tribes will be better informed of their ability to use WBE to measure community health, thereby
protecting community health and building capacity for future applications and research translation.

Public health relevance
PROJECT NARRATIVE SARS-CoV-2 wastewater-based epidemiology is particularly applicable for Tribal communities who wish to improve testing rates, are managing operational plans, or want to observe temporal trends within a defined sewershed. Our approach of analyzing wastewater for human metabolites and pathogens addresses known and well-documented concerns of violation of cultural norms by avoiding the collection and analysis biospecimens of individuals. By effectively working with Tribes, these efforts will culminate in a robust data stream to inform leadership, health administrators and wastewater utilities of coronavirus trends reflective of the population from which samples are collected.